Mechanism of repeat expansion and chromosome fragility in Fragile X syndrome

Background: The Repeat Expansion Diseases are caused by intergenerational expansions of a specific tandem repeat. More than 20 such diseases have been identified thus far. The Fragile X-related disorders (FXDs) arise from expansion of a CGG.CCG-repeat in the 5' UTR of the FMR1 gene. The FXDs are a group of 3 different disorders: Carriers of alleles with 55-200 repeats, so-called premutation (PM) alleles, are at risk for a neurodegenerative disorder, Fragile X-associated tremor-ataxia syndrome and a form of ovarian dysfunction known as FX-associated primary ovarian insufficiency. Furthermore, in females, the premutation allele can undergo expansion on intergenerational transfer that can result in their children having alleles with >200 repeats. This expanded allele is known as a full mutation and individuals who inherit such alleles almost always have Fragile X syndrome (FXS), which is the leading heritable cause of intellectual disability. The mechanism by which is expansion occurs is unknown. It is thought to differ from the generalized microsatellite instability seen in many different cancers in that the instability is confined to a single genetic locus and shows a strong expansion bias. Expanded alleles are also associated with a folate-sensitive fragile site that is coincident with the repeat on the X chromosome. This site, which gives the disorder its name, is one of many fragile sites present on the human genome. These sites are prone to breakage and in some cases are associated with deleterious chromosome deletions and translocations. Progress report: We have previously shown that repeat expansion in our Fragile X premutation mouse model likely arises from aberrant DNA repair. We have also shown that in addition to germline expansion, expansion also occurs in the somatic cells of both mice and humans carriers of Fragile X premutation alleles. Expansion in mice primarily affects brain, testis and liver with very little expansion in heart or blood. Somatic expansion in humans may contribute to the mosaicism often seen in carriers of PM or FM alleles. Since expansion risk and disease severity are related to repeat number, somatic expansion may exacerbate disease severity and contribute to the age-related increased risk of expansion seen on paternal transmission in humans. Since little somatic expansion occurs in murine blood, our data also raise the possibility that there may be discordance in humans between repeat numbers measured in blood and that present in brain. This could explain, at least in part, the variable penetrance seen in some of these disorders and could complicate risk assessment in these disorders. We have previously demonstrated that oxidative damage increases the expansion frequency. We have since identified two different genetic factors directly involved in modulating the level of repeat instability. One of these factors is a DNA repair factor that is required for repeat expansion whilst the second is a DNA damage repair factor that protects the genome against repeat instability. We have also extended our earlier work on chromosome fragility to examine the replication of the FMR1 locus. We had previously shown that ATM and ATR, two important DNA damage response proteins, protect the genome against chromosome fragility. In this reporting period we have studied in some detail a complex origin of replication located in the 5' end of the FMR1 gene. We have shown that replication through the repeat is impaired in patients that express the fragile site. This data is consistent with an early observation from our laboratory showing that secondary structures formed by the repeat present a strong barrier to DNA polymerase (Woodford and Usdin, 1995; Usdin, 1998).